Regulatory Mechanisms Governing BubR1 Protein Stability During Stress and Aging

Abstract:
BubR1 is a key regulator of aging through suppressing cellular senescence and is a critical tumor suppressor
through its role in maintaining genome integrity by sustaining fidelity in chromosomal segregation during
mitosis through control of the spindle assembly checkpoint. Importantly, BubR1 levels decline with age putting
it at the intersection of aging and age-related diseases such as cancer. Loss of BubR1 with age is attributed, in
part, through its increased ubiquitin-proteasomal mediated degradation, which can be blocked by increasing
the activity of the NAD+-dependent deacetylase SIRT2. However, the E3 ubiquitin ligase(s) involved in
promoting the decline in BubR1 with age and under conditions of stress remain elusive.
We identified the Skp1-Cullin-F-box (SCF) E3 ubiquitin ligase substrate recognition subunit -TRCP1
as an interactor of BubR1, which targets BubR1 for ubiquitination and degradation. BubR1 contains a putative
binding domain for -TRCP1 (known as a degron motif), which lies adjacent to the acetylated lysine controlled
by SIRT2 suggesting a cross talk between SIRT2-regulated acetylation and ubiquitination of BubR1 by -
TRCP1. Furthermore, -TRCP1 is involved in ubiquitination and degradation of key regulators of genome
stability and cancer such as CHK1 and Cyclin D1 in response to cellular stress, including nutrient deprivation.
Similarly, BubR1 protein levels are destabilized in response to glucose deprivation, suggesting a putative role
for -TRCP1 in regulating BubR1 under physiological stress conditions as well as during the natural aging
process. Based on these observations, we hypothesize that -TRCP1 is a key regulator of BubR1 protein
stability to control aging and disease.
To test this hypothesis, we developed two specific aims. In aim 1 we will define the posttranslational
regulation of BubR1 by -TRCP1 at the molecular level, and its impact on cellular senescence and organismal
lifespan. These studies will investigate the upstream and downstream pathways by which -TRCP regulates
BubR1 protein stability, and its involvement in the promoting the decline of BubR1 with age. In aim 2 we will
determine the role of -TRCP1-mediated protein degradation of BubR1 under conditions of cellular stress
including glucose deprivation by delineating the molecular mechanisms linking cellular sensing of nutrient
stress to ubiquitin-proteasomal mediated degradation of BubR1. In addition, we will assess the consequences
of altering BubR1 and other regulators of genome stability in the cellular response to glucose restrictive
conditions. Finally, we will elucidate the role of -TRCP1 in proteome remodeling during the cellular response
to glucose restriction conditions using an unbiased proteomics-based interaction screen. The overall goal of
this proposal is to elucidate at the molecular and cellular level the role of -TRCP in controlling key regulators
of genomic stability including BubR1 during cellular stress in aging and disease, which will provide the impetus
to develop novel therapeutic interventions for aging and age-related diseases through stabilization of BubR1.

Public health relevance
Project Narrative: BubR1 is a key regulator of genomic integrity through controlling the spindle assembly checkpoint and also suppresses the process of cellular senescence, thus it is a key factor regulating the interrelationship between cellular stress, cancer, and aging. Protein levels of BubR1 are lost following cell stress such as glucose deprivation and decline naturally during the aging process in a wide variety of tissues, which can be reversed by preventing its ubiquitin-mediated degradation by the deacetylase SIRT2, however the molecular mechanisms promoting ubiquitination of BubR1 during stress and with age remain elusive. In this proposal we will define the role of the E3 ubiquitin ligase SCF-TRCP1 in promoting BubR1 degradation under these conditions, which will provide the impetus to target BubR1 stabilization as a therapeutic strategy against age- related diseases.